Research Advising and Mentoring Professionals (RAMP) program.

The biomedical workforce strives to address health concerns of local and global significance. To support undergraduate students pursuing biomedical degrees, our Research Advising and Mentoring Professionals (RAMP) program will build on successes, experiences, and lessons learned from UAF’s Biomedical Learning and Student Training (BLaST), our NIH-funded program. Specifically, the RAMP program will develop, deliver, and evaluate a comprehensive and customized mentor training program that focuses on supporting faculty, graduate students, and research staff located across the country at institutions that serve undergraduate students in biomedical research. This intensive, year-long training program, augmented with continuing support from RAMP staff and network resources, will administer a supportive approach to create a network of mentors who possess the knowledge and skills they require to provide academic advising, research mentoring, and functional support to the students they serve.

Public health relevance
Undergraduate students are seeking to join the biomedical workforce that addresses health concerns of local and global significance. The Research Advising and Mentoring Professionals (RAMP) program will develop, deliver, and evaluate a customized, comprehensive mentor training program that focuses on supporting faculty, graduate students, and research staff located across the country at institutions that serve undergraduate students in biomedical research. This intensive training will administer a supportive approach to create a network of trained mentors who possess the knowledge and skills they require to provide academic advising, research mentoring, and functional support to the students they serve.